SUBLINGUAL TESTOSTERONE FOR HORMONAL REPLACEMENT THERAPY IN HYPOGONADAL MEN

To characterize the bioactivity of the SL testosterone preparation on metabolic activities of bone, muscle and metabolism as well as possible adverse effects of testosterone replacement and the cardiorespiratory system.